COBRE in Digestive and Liver Diseases

Abstract of Funded Parent Award
The overall goal of the Center of Biomedical Research Excellence (COBRE) in Digestive & Liver Diseases
(CDLD) is to enable outstanding multidisciplinary collaborative research in digestive and liver diseases at the
Medical University of South Carolina. These diseases are of importance to the state of South Carolina because
of the tremendous, disproportionate burden they have upon the state’s citizens. The specific aims are to: 1)
Mentor an expanding cadre of successful Junior Investigators to become independently funded in digestive and
liver disease research; 2) Develop innovative scientific core resources designed to stimulate and apply research
discoveries in digestive and liver disease to improve human health; and 3) Sustain the CDLD and its long-term
success through multidisciplinary research and programmatic evaluation and improvement strategies. The
Center is led by a multidisciplinary team of two department chairs within the MUSC College of Medicine,
coalescing resources to achieve their overarching objective of developing an NIDDK-funded Silvio O. Conte
Digestive Disease Research Core Center at MUSC. Scientific cores include the: 1) Cell Models Core to generate
advanced cell models of digestive and liver diseases; 2) Animal Models of Digestive Diseases Core to provide
access to essential animal models; and 3) Advanced Imaging Core with sophisticated equipment, technologies
and expertise required for successful, state-of-the-art cell and tissue-based imaging and analysis. This
application highlights four Junior Investigators who will benefit from an innovative multiple source mentoring plan
which features both internal and external mentors. With NIH and institutional support, the COBRE in Digestive
& Liver Disease will facilitate the development of robust translational programs, ultimately leading to better
mechanistic understanding with the potential for new therapeutic discoveries.

Public health relevance
Project Narrative There will be no change in the parent grant resulting from this proposed supplement. Gastrointestinal diseases are a tremendous burden for many US citizens with treatment costs estimated to be more than $120 billion annually in the US. This initiative will establish a center of excellence in digestive and liver disease in South Carolina where the population bears a disproportionate burden of disease.